The Renin-Angiotensin System in Air Pollution-Mediated Exacerbation of Obesity.

Significance. Exposure to traffic-generated particulate matter (PM), a significant source of ambient air pollution,
is associated with adverse health outcomes, including metabolic disorder and obesity, rates of which are
increasing in children and adults worldwide. However, the pathways involved in promoting an obese adipose
phenotype resulting from PM exposure are not fully understood. An “unhealthy” gut microbiome and increased
tissue-specific adipose renin-angiotensin system (RAS) signaling are both associated with obesity; however, the
signaling pathways that link these two factors have not been fully characterized, especially related to
environmental PM exposure. Thus, whether PM exposure mediates abnormal gut microbiota profiles that
promote alterations in short-chain fatty acid (SCFA) and glucagon-like peptide (GLP)-1 signaling in the intestines
will be determined. Elucidating the role of GLP-1 on tissue level RAS signaling in adipocytes may provide novel
targets for future therapies for susceptible individuals living in regions with high urban air pollution levels.
Innovation. The proposed experiments will analyze the cross-talk between SCFA, GLP-1, and RAS signaling in
adipose tissue to determine whether inhalation exposure to diesel engine exhaust PM (DEP) results in altered
gut microbiome profiles associated with deregulation of GLP-1-mediated RAS signaling and subsequent
alterations in the adipose structure and metabolic/endocrine function associated with obesity. Importantly, these
analyses will be conducted in tissues derived from male and female C57BL/6 mice, using characterized DEP,
and appropriate pharmaceutical interventions (GLP-1 agonist, probiotics), to simulate exposure scenarios and
underlying pathophysiologic states similar to that in the human population. Adipocyte cell culture will be used to
further investigate the mechanism and 16S Next-Generation Sequencing, NanoString, and Multiplex
methodologies to reveal alterations in the gut microbiome and metabolic/endocrine pathways involved in obesity.
Specific Aims. The preliminary data shows that exposure to mixed vehicle engine emissions results in weight
gain, adipocyte hypertrophy, and elevated adipose tissue level RAS in male C57BL/6 mice; however, the role of
DEP has not been investigated as a contributing causative component in these outcomes. Thus, the hypothesis
that inhalational DEP exposure promotes obesogenic profiles in adipose tissue through deregulation of GLP-1 –
Ang II signaling will be investigated. In Aim 1, the outcome of inhaled DEP on gut microbiota profiles and SCFA
signaling in regulating GLP-1 expression and RAS-mediated adipocyte hypertrophy and adipokine signaling will
be analyzed C57BL/6 male and female mice using a probiotic treatment. DEP-mediated alterations in systemic
metabolic and obesogenic gene expression pathways will also be assessed. In Aim 2, it will be determined
whether DEP exposure mediates alterations in GLP-1 on adipocyte RAS signaling and subsequent lipid
accumulation through GLP-1 agonist treatment (in vivo), and also GLP-1 agonist vs. siRNA knockdown of local
GLP-1 receptor signaling (in vitro) in adipocyte cell culture treated with plasma from our study animals.

Public health relevance
The Renin-Angiotensin System in Air Pollution-Mediated Exacerbation of Obesity. Project Narrative. Exposure to traffic-generated particulate matter (PM) air pollution is associated with inflammatory diseases such as obesity, the prevalence of which is currently increasing in youth and adults worldwide. The signaling pathways that mediate the effects of air pollution in promoting metabolic syndrome and obesity are not fully understood; however, increased renin-angiotensin system signaling is observed in adipose tissue from obese individuals, which may be induced from abnormal hormonal signaling from the intestines associated with “unhealthy” microbiota profiles. Therefore, this project will attempt to gain further insight into whether exposure to PM air pollution leads to deregulated intestine glucagon-like peptide (GLP)-1 signaling associated with an altered intestine microbiome that induces renin-angiotensin system signaling in adipose tissue, promoting obesity. PHS 398/2590 (Rev. 09/04, Reissued 4/2006) Page Continuation Format Page